MULTICENTER INVESTIGATION OF NONTUBERCULOUS MYCOBACTERIA IN PATIENTS WITH CF

The overall objective of this clinical investigation is to determine the impact of nontuberculous mycobacteria on the natural course of cystic fibrosis lung disease in the U.S.